Disseminating PCOR findings to Reduce Racial Disparities in Surgical Sterilization

Abstract:
This proposal, submitted in response to RFA-HS-22-001, in the priority area of “improving maternal health,” is
prompted by long-standing racial and ethnic disparities in use of permanent contraception (historically called
“surgical sterilization”). In the US, permanent contraceptive procedures are most commonly performed on
women of color, women with chronic conditions such as diabetes, and those residing in rural communities.
Although permanent contraception aligns well with some patients’ reproductive life plans, reports that 10% of
women regret having undergone these procedures are troubling. These regrets and racial disparities are
especially problematic given recent PCOR demonstrating that long-acting reversible contraceptives, such as
hormonal IUDs are both more effective and less likely to cause pelvic pain than permanent contraceptive
procedures. To disseminate PCOR about the comparative safety and real-world effectiveness of alternatives to
permanent contraception, we will adapt the advance care planning (ACP) framework, which has been used to
ensure that patients receive medical care when approaching their end of life that aligns with their personal
treatment goals. This paradigm is a critical tool for supporting patients in making complex medical decisions,
by emphasizing elicitation of values, communication skill building, and shared decision-making. By preparing
patients approaching the end of their reproductive life to more effectively communicate to clinicians their
personal values, priorities, and treatment goals, we will adapt the ACP model for reproductive life planning
(RLP), with input from patients (Aim 1, focus groups) and clinicians (Aim 2, semi-structured interviews). We will
then conduct an individual-level randomized clinical trial comparing this approach to disseminating PCOR
relevant to discussions of permanent contraception with 300 women who identify as Black or have a chronic
condition such as diabetes, and who wish to avoid future pregnancy (Aim 3). In evaluating this intervention, our
experienced multi-disciplinary team will carefully examine patient-reported outcomes related to communication
and satisfaction with care. We will also rigorously analyze heterogeneity of treatment effects by clinical and
patient-level contextual factors to inform the potential need for future refinement of this ACP-RLP paradigm. By
increasing equitable access to alternatives to permanent contraception, this project strives to increase the
proportion of US women who are using a method of contraception that aligns with their personal preferences
and reduce the proportion of individuals who regret having undergone a permanent contraceptive procedure.

Public health relevance
Narrative: This proposal seeks to address long-standing racial and ethnic disparities in use of permanent contraception (historically called “surgical sterilization”) by disseminating PCOR on the comparative safety and effectiveness of long-acting contraceptives. Although permanent contraception aligns well with some patients’ reproductive life plans, reports that 10% of women regret having undergone these procedures are troubling. By increasing equitable access to alternatives to permanent contraception, this project strives to increase the proportion of US women who are using a method of contraception that aligns with their personal preferences and reduce the proportion of individuals who regret having undergone a permanent contraceptive procedure.